SITE LICENSE TO AJCC CANCER STAGING MANUAL, 8TH EDITION

In order to continue the collection and reporting of cancer staging data by the SEER registries, the NCI/DCCPS SEER program requires access to the most current cancer staging data.